Development of Once-daily Oral Treatment for Maple Syrup Urine Disease

Project Abstract
Syntis Bio is advancing SYNT-213, a potentially transformative therapeutic approach for Maple
Syrup Urine Disease (MSUD). This once-daily oral therapy combines the innovative
gastrointestinal synthetic epithelial lining (SYNT™) with a protease-stable leucine decarboxylase
enzyme (CDX-6210) to potentially extend enzyme activity in the small intestine. By targeting both
dietary and recirculated leucine, SYNT-213 may offer a paradigm shift in gut-restricted oral
enzyme replacement therapies. This project aims to optimize SYNT-213 for robust gastrointestinal
adhesion and enzyme stability, with the potential to significantly reduce leucine levels in preclinical
MSUD models. The goal is to develop a solid dosage form that may simplify administration,
offering a long-term, disease-modifying treatment for MSUD patients and potentially improving
clinical outcomes through enhanced dietary flexibility.

Public health relevance
Project Narrative Syntis Bio is developing SYNT-213, a once-daily oral enzyme therapy with extended activity to offer long-term, disease-modifying treatment for MSUD patients.